Elucidating dietary fructose and alcohol interactions during liver cancer development

PROJECT SUMMARY/ABSTRACT
The primary objective of this NIAAA R01 Supplement is to equip Ms. Miranda Lopez, an underrepresented
graduate student candidate, with the skills and knowledge necessary to become a proficient and independent
scientist while completing her proposed research project on deciphering mechanisms of alcohol/fructose-
induced hepatocellular carcinoma (HCC), a natural extension of the parent R01 award. Dr. Cholsoon Jang, the
lead mentor, and Dr. Dequina Nicholas, the co-mentor, possess the requisite proficiency and knowledge to
offer an optimal co-mentorship for both the accomplishment of her project and her career growth. Specifically,
Dr. Jang has expertise in nutrition and cancer biology and Dr. Nicholas has expertise in immunology and has
plenty of experience in mentoring underrepresented minority students. Further, to ensure Ms. Lopez's career
development, we have enlisted two senior faculty members to serve on her mentoring committee. During the
diversity supplement period, Ms. Lopez will perform experiments to determine the role of specific lipid pathway
in alcohol/fructose-induced HCC (Candidate Aim 1). She will also determine whether immunomodulation is
involved in HCC tumor growth (Candidate Aim 2). Both aims are a natural extension of Aim 1 of the parent
award: “whether and how fructose and alcohol synergistically increase HCC risk”. Although antiviral treatment
has proven effective in preventing virus-associated HCC, the origin of the cancer is now transitioning from viral
hepatitis to metabolic disorders that stem from lifestyle choices, including non-alcoholic and alcoholic
steatohepatitis. In the parent award, we hypothesized that fructose shifts the metabolic fate of alcohol toward
carcinogenic metabolite production via induction of acetyl-CoA synthetase 2 (ACSS2), a cytosolic enzyme that
catabolizes acetate to acetyl-CoA. In Aim 1, we aim to determine whether and how fructose and alcohol
synergistically increase HCC risk. In Aim 2, we aim to determine whether ACSS2 inhibition and/or gut
microbiota depletion suppresses fructose and alcohol-induced HCC. In Aim 1 of the parent grant, we
discovered, by our unbiased untargeted metabolomic, that alcohol/fructose-induced HCC showed a profound
accumulation of very long-chain polyunsaturated fatty acids (VLC-PUFA). Furthermore, blood VLC-PUFA
strongly correlates with HCC burden, suggesting an exciting possibility of using serum VLC-PUFA as an HCC
diagnostic marker. VLC-PUFA are synthesized by ELOVL2 (elongation of very long chain fatty acids protein 2),
and we found that ELOVL2 proteins are 3-fold higher in tumors. Recently, VLC-PUFA has been shown to inhibit
dendritic cell differentiation and reduce cytotoxic T cells. Therefore, Mr. Lopez will determine whether blocking
ELOVL2 suppresses alcohol/fructose-induced HCC and whether VLC-PUFA-mediated immune suppression is
the key underlying mechanisms of HCC progression. As she undertakes the proposed research, she will receive
a broad range of training, including developing expertise in experimental techniques, cultivating research
independence, honing her scientific communication skills, and mastering the art of grantsmanship, among others.

Public health relevance
The supplement instructions PA‐21-071 state: “At minimum, the Research Strategy section should be completed and must include a summary or abstract of the funded parent award or project. Other sections should also be included if they are being changed by the proposed supplement activities.” The original Project Narrative document has not changed as a result of the proposed supplement activities.